Biological and Psychosocial Mechanisms Underlying Oral Inflammation and Disease

PROJECT SUMMARY/ABSTRACT
Periodontal diseases affect nearly half of all adults in the US, and the physical, psychological, and financial
burdens of these conditions fall disproportionally on non-white and lower-income Americans. Oral health
disparities persist in parallel with disparities in several systemic health conditions, including type 2 diabetes (T2D)
- one of the leading causes of death in the US. T2D and periodontal disease (PD) have well-characterized
reciprocal relations with shared risk factors and inflammatory mechanisms driving increased risk for both
conditions. Recent evidence suggests that unresolved oral inflammation pays a key role in the onset and
progression of both PD and T2D. However, what causes exacerbated oral inflammation in some individuals and
not others remains elusive. This study focuses on the psychosocial and environmental sensitivity of oral
inflammatory processes as a key driver of disparities in PD and T2D risk. This project’s overall objective is to
determine the role of various sources of oral inflammation and psychosocial risk factors in mediating relations
linking race, ethnicity, and SES with PD and T2D risk. The central hypothesis is that exposure to individual (e.g.,
chronic stress) and structural (e.g., pollution) psychosocial stressors and adversities can increase oral
inflammation via several mechanisms, which can, in turn, increase PD and T2D risk. This project further
examines whether the downstream consequences of these psychosocial factors on oral inflammation partially
explain disparities in PD and T2D risk associated with race, ethnicity, and SES. To address these hypotheses,
a longitudinal study of the biologic and psychosocial factors underlying oral inflammation and disease risk will
be conducted with our clinical partners in a diverse, community-based sample of 350 adults. Biologic,
psychosocial, and clinical assessments will be conducted at baseline and two years later to allow for the
examination of three specific aims:1) examine various biologic processes contributing to oral inflammation and
their associations with current and future PD risk/severity; 2) examine associations between psychosocial stress
and structural adversities and current and future oral inflammation; and 3) examine relations between oral
inflammation and current and future T2D risk. Through completion of this project, common, modifiable biologic
and psychosocial mechanisms contributing to oral inflammation and disparities in PD and T2D risk will be
elucidated. Findings from this study could help identity new, innovative prevention, screening, and intervention
strategies for PD and T2D, both of which are reversable conditions if intervention is initiated early in the disease
course (e.g., at the onset of gingivitis and prediabetes). These findings will also inform an integrated
understanding of health disparities in the US and help advance public health and clinical interventions that
maximize efficiency and impact by targeting factors underpinning health across multiple domains.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health because it focuses on common, modifiable biologic and psychosocial factors contributing to disparities in two highly-prevalent and preventable conditions affecting millions of Americans - periodontal disease (PD) and type 2 diabetes (T2D). Using salivary biomarkers and clinical and self-report data collected from a diverse sample of adults, this project examines the psychosocial and environmental sensitivity of oral inflammatory processes as a key driver of disparities in PD and T2D risk. Findings from this study could help identity innovative public health and clinical screening and intervention strategies for PD and T2D making the aims of this project consistent with the Healthy People 2030 goals and with the missions of the National Institutes of Dental and Craniofacial Research and Minority Health and Health Disparities that focus on the social determinants of health, reducing disease, and increasing health equity.